Multiscale Modeling of Clotting Risk in Atrial Fibrillation

PROJECT SUMMARY This project will develop clinically validated multiscale models of cardiac dynamics that integrate ﬂuid dynamics, electromechanical coupling, and ﬂuid-structure interaction (FSI) to simulate intracardiac ﬂows and blood co- agulation in atrial ﬁbrillation (AF). AF is the most common sustained arrhythmia in the U.S. and is associated with serious complications, including thromboembolism and stroke. Anticoagulation is commonly prescribed to patients who have an elevated stroke risk. However, current risk assessment indices, which lack individualization based upon atrial structure or function, classify most AF patients as being at intermediate risk. The core hypothe- sis of this research is that treatment guidelines using current risk assessment metrics result in many AF patients receiving unneeded anticoagulation and unnecessary monitoring for thrombosis. The long-term objective of this research is to develop new, broad-spectrum approaches to clotting risk assessment in AF that provide personal- ized risk prediction. The scientiﬁc premise of this proposal is that comprehensive models of atrial dysfunction will enable mechanistic studies of ﬂow and clotting in AF that will ultimately facilitate individualized treatment. In AF, most clinically signiﬁcant thrombi form in the left atrial appendage (LAA). The anatomy of the LAA is extremely heterogeneous, and although there is an emerging appreciation that LAA anatomy affects clotting risk, anatomy is not considered in current guidelines. Computer models provide ideal platforms for studying the impact of structural and functional variations on LAA ﬂow patterns, but most existing cardiac ﬂuid dynamics models focus on the ventricles. Further, no existing FSI model of the atria includes a detailed description of the LAA, which, like the ventricles and unlike the main LA cavity, is highly trabeculated. A key innovation of this project is that it will develop clinically validated FSI models of cardiac ﬂow in patient-speciﬁc descriptions of LA anatomies, including realistic models of the LAA. These models will be extended to include biophysically detailed models of coagulation dynamics and clot transport. This project aims both to establish these models and also to apply them to study ﬂows and clotting dynamics in two therapies for AF: (1) percutaneous LAA exclusion via the WATCHMAN device and (2) electrically isolating the LAA in catheter ablation therapy. In the case of LAA exclusion, the incidence of device-associated thrombosis is 3.4%; consequently, post-operative anticoagulation therapy is currently used in all patients receiving these devices. Electrical isolation of the LAA is rarely performed because of concerns about its effect on systolic ﬂow and stroke risk, and the inability to identify patients who would beneﬁt. The core modeling approaches developed in this project can also be deployed to simulate thrombogenesis in a range of signiﬁcant medical conditions (venous thromboembolism, deep vein thrombosis), medical devices (prosthetic heart valves, ventricular assist devices, IVC ﬁlters), and novel biomaterials. Ultimately, models using this platform are expected to be submitted to the FDA Medical Device Development Tools program as non-clinical assessment models to predict pre-clinical device performance in regulatory submissions.

Public health relevance
PROJECT NARRATIVE This project aims to develop multiscale computational models for predicting clotting in patients with atrial ﬁbrilla- tion (AF). AF is the most common heart rhythm disorder in the United States, and AF patients have an increased risk of developing blood clots that can cause serious medical complications, including strokes. Tools for modeling blood ﬂow and clotting in AF and treatments for AF promise to improve clinical risk assessment for these patients.